Ecological Momentary Assessment of Negative Urgency's Effects on Alcohol and Marijuana Misuse

PROJECT SUMMARY Negative urgency, a tendency to rash action in the face of negative emotions, is one of the strongest personality predictors of alcohol and marijuana misuse (heavy use, intoxication, and the experience of consequences). In the face of strong negative emotions, people high on negative urgency are theorized to engage in impulsive behavior that is hyper-focused on relieving negative affect despite the long-term consequences, negatively reinforcing impulsive behavior. However, no research has tested whether individuals high on urgency actually behave more impulsively in the face of negative emotions, what situations might enhance or buffer this effect, or what role affect-driven impulsivity plays in the development of alcohol and marijuana misuse during young adulthood. The goal of the current study is to (Aim 1) characterize the within- person process of negative urgency (Aim 2) identify between and within person moderators of that process, such as alcohol-promoting situations and emotion regulation, and (Aim 3) test the role of EMA-assessed urgency in the development of alcohol and marijuana misuse over two years of young adulthood. Using a large (n = 500) sample of young adults (age 18 – 22) who regularly use alcohol or marijuana recruited from the community, the proposed study will critically test this theory of urgency using an ecological momentary assessment design matched with longitudinal follow-ups, allowing us to characterize between individual differences in the within-person process of impulsive responses to negative emotions, and the situations and behaviors that may exacerbate or attenuate this link. Understanding the mechanisms by which personality may lead to substance misuse will provide novel targets of research as well as spur the development of more focused personality targeted interventions. The following was appended in April 2021 for the purposes of an administrative supplement to the original grant. National Institute on Drug Abuse (NIDA) Intern Role A Summer Research Intern selected through the NIDA Summer Research Internship Program will join the project and engage with research staff and participants. They will be trained in human subjects research and the study protocol; roughly 60% of their time will be dedicated to study tasks such as meeting with participants for the onboarding appointment and attending meetings with research assistants. The other 40% of their time will be spent engaging in training and literature review guided by Dr. Kevin King. These efforts will be undertaken with the goal of building the intern’s knowledge of study-related research on impulsivity and substance use. Some flexibility will be allowed so that the intern and mentor (Dr. King) might customize their training toward their particular interests within the scope of the study.

Public health relevance
PROJECT NARRATIVE This project will describe individual differences in impulsive responses to negative emotions in the real-world. We will test what situational factors and emotion regulation skills make some people more or less impulsive in the face of negative emotions, and how the interplay between negative emotions and impulsive behaviors could lead to alcohol and marijuana misuse in the real world. This project will be able to elucidate when, how and for whom impulsive responses to emotion leads to alcohol and marijuana misuse.